Combining a Smartphone App with Medications to Manage Heavy Drinking

Background: Alcohol use disorder (AUD) affects 1 in 10 Veterans and is associated with significant morbidity
and mortality. However, few individuals receive evidenced-based psychosocial interventions or medications for
AUD (MAUD). Common barriers to treatment include long wait times, stigma, and distance from treatment
facilities. Despite clinical guidelines and evidence indicating superior outcomes, even fewer individuals receive
MAUD and psychosocial interventions conjointly. The VA prioritizes expanding access to AUD interventions in
primary care, but it is difficult to deliver psychosocial interventions in primary care, and care often includes
MAUD only. Smartphone mobile applications (apps) that deliver psychosocial interventions concurrent with
MAUD may address the gap between recommended and current practices for AUD and appeal to Veterans
who prefer to receive their AUD care in primary care. Alcohol intervention apps have been associated with
improved drinking-related and mental health outcomes. Self-monitoring of alcohol use, a common feature in
apps, may also increase MAUD adherence. Step Away, an app for self-management of alcohol use problems,
is designed to guide development and use of personalized strategies to moderate or abstain from drinking. In
single-arm cohort studies, we assessed the acceptability and usability of Step Away and Stand Down (SD-
App), the Veteran version of the app and focus of this proposal, among Veterans with alcohol use problems.
The apps received favorable ratings regarding perceived effectiveness, efficiency, and overall satisfaction, and
were associated with reductions in heavy drinking days and drinking-related consequences.
Significance: This study has the potential to substantially improve Veterans’ receipt of guideline-concordant
AUD care and support national VA initiatives to increase access to AUD care in general healthcare clinics.
Innovation & Impact: To our knowledge, no prior study has evaluated the effectiveness of an alcohol-related
intervention, delivered by smartphone, with MAUD in primary care. Smartphone apps can be scaled up at
relatively low cost, potentially saving lives and improving the quality of care of tens of thousands of Veterans.
Specific Aims: Our two aims are to: 1) determine whether MAUD plus SD-App offered to primary care
patients diagnosed with AUD, compared to MAUD only, results in (a) greater reductions in heavy drinking
days, from baseline to 6-months (primary), (b) greater improvements in alcohol consequences, alcohol use risk
levels, and mental health outcomes, from baseline to 6-months (secondary), 2) conduct a process evaluation
to identify factors that influence the adoption, implementation, and sustainability of SD-App in combination with
MAUD in VA primary care from Veterans’, clinical pharmacist specialists’ and clinical leaders’ perspectives. We
will also explore whether MAUD plus SD-App increases MAUD 6-month adherence relative to SD-App alone.
Methodology: Guided by the Reach, Effectiveness, Adoption, Implementation, and Maintenance framework,
this Hybrid 1 effectiveness-implementation trial will enroll 330 Veterans across 10 VA sites. Veterans between
ages 18-80, meeting AUD criteria, and planning to initiate MAUD will be randomized to MAUD+SD-App or
MAUD only. Participants randomized to MAUD+SD-App will receive access to SD-App. MAUD will be
prescribed by primary care-based clinical pharmacists per standard clinical care. The primary and secondary
outcomes will be assessed at baseline, 3-, 6- and 12-months using participant self-report and electronic
medical record data. We will complete qualitative interviews to assess Veterans’, clinical pharmacists’, and
clinical leaders’ perspectives on barriers and facilitators to adoption, implementation, and sustainability of SD-
App in combination with MAUD in primary care.
Next Steps/Implementation: If MAUD+SD-App improves drinking outcomes, we will work closely with our
operations partners to review study findings and to develop a tailored implementation strategy to support
widespread implementation across VA primary care.

Public health relevance
One in 10 Veterans have an alcohol use disorder. However, few Veterans receive evidenced-based psychosocial interventions or medications to treat alcohol use disorder. Barriers to receiving these treatments include long wait times, stigma, and long distances from treatment facilities. Even fewer Veterans receive psychosocial and medication interventions together, despite clinical practice guidelines recommending both and evidence of better outcomes. Expanding access to these treatments in primary care is a VA priority but delivering psychosocial interventions is difficult in this setting, and medication is often the only option. Smartphone apps that deliver alcohol interventions may improve drinking outcomes and ensure Veterans can receive both treatments in primary care. This study will determine whether medications and an app for alcohol use problems offered to Veterans in primary care results in improved drinking outcomes, compared to Veterans receiving medications only. Study data will inform how to spread the app across the VA nationally.